CORE A: Administrative Core, Enrichment Program, Biostatistic Clinical Component

The overarching goal of the Administrative Core is to support the continuing development of the VDDRC Research Base and to ensure responsiveness of the Research Cores to the needs of VDDRC members and Pilot Project grant recipients. The administrative and scientific leadership of the VDDRC is provided by the Director, Richard Peek, and the Associate Directors, Naji Abumrad and Keith Wilson, and is augmented by the Scientific Advisory Board, composed of renowned internal and external investigators, and by the Executive Committee, which is comprised of the Director, Associate Directors, Core Directors, and Program Leaders. One administrative assistant provides the necessary support for day-to-day financial management and operations of the VDDRC. Vanderbilt University Medical Center provides exceptional institutional support and infrastructure to promote the continued growth of our center. The Administrative Core supports a Biostatistical Program directed by Dr. Tatsuki Koyama to assist pilot project applicants and recipients as well as our members in clinical and basic research study design, data analysis, and database management. An Enrichment Program co-directed by Dr. Abumrad, fosters new investigation in digestive diseases research by supporting prominent scientists to present research seminars at Vanderbilt, enhancing core utilization by addressing member research needs, and through an annual retreat. The seminar series and the retreat provide opportunities for communication and promote collaboration through scientific and technical interactions between members and Core Directors. The Enrichment Program also supports acquisition of new skills through the Enrichment Training (mini-sabbatical) Program. The Clinical Component of the VDDRC Is directed by Dr. Abumrad and provides clinical and translational platforms for VDDRC investigators to transition mechanistic studies into appropriate human populations. The Administrative Core oversees the Pilot and Feasibility Project Program, which has invested >$1.9M into investigator-initiated research since inception of the VDDRC and is directed by Dr. Wilson. This program is designed to attract new and seasoned investigators to pursue digestive diseases research in the four research areas of the VDDRC: 1) Growth, proliferation and apoptosis; 2) Epithelial integrity; 3), Gastrointestinal physiology, obesity and metabolism; and 4) Gastrointestinal development and function.

Public health relevance
The VDDRC greatly enhances research in digestive diseases at Vanderbilt University with the intent to improve the prevention, diagnosis or treatment of human gastrointestinal disorders.